Administrative Core

Abstract
The goal of the Administrative and Coordinating (A&C) Core is to oversee the administration of the East Africa
Consortium for HPV and Cervical Cancer (EACHC) in Women Living with HIV/AIDS. The A&C Core coordinates
the activities of all investigators involved on three projects and the three additional cores (Biostatistics and Data
Management; Translational Biology; and Developmental), and to facilitate communication within and between
the North American, Ugandan and Kenyan institutions and other organizations in which the EACHC will directly
interact. The Administrative and Coordinating Core will also be responsible for dissemination of information
within participants of the EACHC, and outside of the EACHC through an External Advisory Committee, which
will provide additional advice on pilot projects and on mechanisms to enhance community outreach and
engagement.
The rationale for central communication and data flow through this centralized approach is to maximize intra-
institutional, inter-institutional and inter-country collaborations through this unique partnership and to adjudicate
any potential conflicts as they arise.
The specific services provided by this Core follow from its Aims:
Specific Aim 1: To facilitate communication, resolve potential conflicts and maximize the research infrastructure
supporting the investigators of each of the EACHC projects and cores;
Specific Aim 2: To disseminate research findings between the consortium members in East Africa and North
America; and
Specific Aim 3: To leverage the research conducted by the EACHC with the community stakeholders with other
external entities to impact the morbidity and mortality of cervical cancer and other AIDS-associated malignancies.
These aims will be accomplished through the Partnership Coordinating Activities and with assistance from the
External Advisory Board as outlined herein.

Public health relevance
Narrative The overall goal of the Administrative and Coordination Core is to oversee the administration of the East Africa Consortium for HPV and Cervical Cancer (EACHC) in Women Living with HIV/AIDS. The A&C Core also coordinates the activities of all investigators involved on three projects and the three additional cores, and to facilitate communication within and between the North American, Ugandan and Kenyan institutions and other organizations in which the EACHC will directly interact.